Computational approaches to delineate non-canonical splicing events

Abstract:
RNA splicing generates enormous variations at the RNA and protein levels to regulate cell-type-
specific functions as well as being the cause for numerous diseases. Several classes of splicing
patterns have been widely studied, such as exon skipping, intron retention and alternative
splicing sites. Advances in sequencing technologies enable the discovery of previously
unknown non-canonical splicing events. However, due to the lack of dedicated computational
approaches, the prevalence and functional consequences of these non-canonical splicing
events remain unexplored. The goal of our research program in the next five years is to develop
novel and specialized computational algorithms for discovery and characterization of emerging
splicing patterns that are currently understudied. We will focus on exitrons and non-linear-
spliced transcripts in our proposed study, as these two non-canonical splicing models have
been implicated in complex human diseases reported by recent studies. We will develop a
series of algorithms to (1) comprehensively catalog these novel splicing patterns using short
and long read sequencing platforms, (2) dissect the genetic basis of non-canonical splicing
events with integrative analysis of deep transcriptome and whole-genome sequencing data, and
(3) elucidate the functional impacts of novel forms of RNA splicing alternations using a
proteogenomic strategy. Our proposed work is innovative in that we will build unique
computational frameworks to detect and characterize novel non-canonical splicing events by
integrating large multi-omics datasets (e.g. TCGA, GTEx and ENCODE). It is significant
because it can be applied both in basic research to improve transcriptome annotation and
potentially in genomic medicine to guide the development of novel therapeutic strategies for
complex diseases.

Public health relevance
Project Narrative The proposed research investigates different types of non-canonical molecular events expressed in RNA that can change the sequence of genes and spark abnormal disease-causing proteins. By developing innovative computer algorithms for analyzing population-scale datasets, we will systematically detect these previously unexplored events and highlight their functional relevance to health and disease. We will distribute the developed tools in open-source software packages to benefit the scientific and biomedical communities.